Decision-Making Under Uncertainty in Prostate Cancer

DESCRIPTION: (provided by applicant) The proposed study tests the efficacy of a decision-making intervention to help men newly diagnosed with prostate cancer become informed participants in the decision-making process with the physician. Since there is no preferred treatment for prostate cancer, the situation is one of therapeutic uncertainty from the perspective of the physician and one of informational uncertainty experienced by newly diagnosed cancer patients. Two approaches for the delivery of the intervention will be tested: intervention delivered to the patient only (treatment direct) or intervention to the patient and his primary support person (treatment supplemented). The intervention will focus on providing the patient with information about treatment options via a nurse-delivered telephone protocol. The information will be supplemented with decision aids including a study-designed portal to selected Internet sites on decision-making in prostate cancer. The intervention will also focus on communication skills training to enhance patient communicator behaviors. The decision-making intervention will be tested with Caucasian and African-American men within the 2-3 week period between receiving a cancer diagnosis and meeting with the physician to discuss treatment options. The design is a 2 X 3 randomized block, repeated measures design with 3 levels of intervention (treatment direct, treatment supplemented, and control condition) crossed with 2 levels of ethnicity. Measures will be taken at baseline and at 4 weeks and 4 months post baseline. Men who receive the decision-making intervention are expected to have less decisional regret, less decisional uncertainty, more treatment knowledge, better patient-provider communication, more perceived effective decision-making, more active communication behaviors, and better reported quality of life than the control group. Multivariate models will be used for analysis. Costs of delivering the intervention will be estimated for dissemination of intervention protocol.